Mentorship in Clinical Complementary and Integrative Health Research

Because over 50% of adults in the United States take complementary and integrative health (CIH) natural products for their health, the training of CIH practitioners and scientists to produce high-quality clinical research is imperative to identifying effective products for the safety of the public. As such, this proposal requests a K24 mid-career development award to expand and support mentorship in clinical natural product research by Dr. Ryan Bradley, ND, MPH. Dr. Bradley has demonstrated effective mentorship by the publication of all past mentees, and the progression of multiple mentees from graduate students to formal NIH post-doctoral training awards, and independent training awards. Dr. Bradley is currently a co-Director of the Scholars program within the RAND REACH Center where he provides mentorship for 10 Scholars, and a Program Director and mentor in the NCCIH-funded T90/R90 Building Research across Interdisciplinary Gaps (BRIDG) clinical research training program. Additionally, Dr. Bradley provides mentorship for numerous post-doctoral trainees, including CIH clinicians and PhD scientists. Dr. Bradley is a primary mentor for a trainee in the University of Michigan HEAL K12 program; a T90 trainee who has progressed onto a KL2 award at the UW, a CIH practitioner supported by an NICCH administrative supplement to gain research experience on Dr. Bradley's R01-funded clinical trials, and two post-doctoral trainees from CIH backgrounds in the ORCCAMIND T32 program at Oregon Health & Sciences University. In addition to his position as an Associate Professor in the School of Public Health at UC San Diego, he retains affiliate and adjunct appointments at 2 US-based and 2 international universities, thus Dr. Bradley is extremely well connected to assist mentees in identifying resources and collaborators for their research. The Specific Aims of this proposal are for Dr. Bradley to: 1. Dedicate consistent effort in the mentorship of promising trainees in T32, T90, R90, K and REACH Scholar programs in order to facilitate their progression in research training and independent research (Aim 1); 2. Refine and develop mentoring skills by pursuing additional training in research mentorship and cutting-edge translational science methodologies (Aim 2); and 3. Provide exposure to translational science methods and provide publication opportunities for mentees through the collection of additional preliminary data related to recent clinical trials of specialized pro-resolvin mediators (SPM) and xanthohumol natural products, including product quality assessment, measurement of relevant biomarkers in stored biologic samples, and measurement of additional transcription factors (PCSK9) to extend the research to new clinical populations (Aim 3).

Public health relevance
PUBLIC HEALTH RELEVANCE: The general goal of this application is to support Dr. Bradley in his mentorship of current and future CIH research trainees toward the creation of a cadre of collaborative clinical CIH scientists, such that high quality research is performed on current and emerging CIH therapies to inform patient care and support the public health through the dissemination of rigorous evidence.